Increasing the reliability of clinical microarray data analysis by systematic bia

DESCRIPTION (provided by applicant): Microarray analysis is widely expected to further our understanding of disease phenotypes and yield robust gene expression signature based predictors of clinical outcome. However, as it has been frequently demonstrated in the literature, insufficient understanding of the various key characteristics of clinical microarray data sets, such as their noise structure, often impedes extracting robust, biologically and clinically meaningful results. In this grant we provide preliminary evidence that clinical microarray data sets contain a significant level of systematic bias. We identified sources of the observed technical bias, such as the overall level of mRNA integrity in a given microarray sample. We showed that this affects the expression level of many genes in concert, thus causing spurious correlations in clinical data sets and false associations between genes and clinical variables. In this proposal we are developing a method that correct for such technical biases in clinical microarray data that are produced on the various generally used microarray platforms. In specific aim 2 we will evaluate the overall impact of systematic bias correction in clinical microarray data sets. We will determine whether clinical microarray measurements show better correlation with independent validation or during cross-validation. As our preliminary results indicate, the proposed bias correction significantly increased concordance of gene expression levels with known biological relationships therefore it will likely facilitate the extraction of clinically relevant results from microarray data.

Public health relevance
Microarray analysis enables researchers to quantify almost every gene in a given clinical sample, therefore ask the question which gene(s) shows the most significant correlation with a given disease phenotype, e.g. response to cancer chemotherapy. The thus identified gene can be used as a biomarker or may serve as a therapeutic target. The key problem with microarray analysis is that we must "pay a price" for measuring a large number of genes in a highly parallel fashion: namely, since microarray measurements are not calibrated for measuring each gene individually in an accurate fashion, we often do not know the overall accuracy and reliability of our gene expression profiling, which may eventually mislead our efforts to identify the genes most associated with disease phenotypes. In this grant, we are dealing with an important aspect of this problem. We provided evidence that quality metrics of the RNA samples profiled on a microarray, such as the level of RNA degradation, has a systematic effect on the expression level of many genes. We termed these quality metrics as "bias metrics" and showed that they affect the expression level of many genes in concert, thus causing spurious correlations in clinical data sets and false associations between genes and clinical variables. In this proposal we take advantage of the strong correlation between bias metrics and gene expression levels and develop a method that correct for such technical biases in clinical microarray data. We will also evaluate the overall impact of systematic bias correction in microarray data sets by determining whether clinical microarray measurements show better correlation with independent validation or during cross-validation. As our preliminary results indicate, the proposed bias correction significantly increased concordance of gene expression levels with known biological relationships, therefore it will likely facilitate the extraction of clinically relevant results from microarray data.